Mechanistic Pharmacokinetics and Pharmacodynamics

Abstract
This program seeks firstly to provide increased understanding of pharmacokinetics (PK) and mechanisms of
corticosteroid (CS) effects on genomic, proteomic, and physiologic processes associated with endocrine,
metabolic, and pharmacologic responses from local to systems levels for CS dosed acutely and chronically.
Secondly, the mechanisms of action and interaction of multiple agents offering potential joint therapy of
pancreatic cancer will be examined. Thirdly, these specific study results will be integrated with relevant
information from the literature to develop improved mechanism-based PK and pharmacodynamic (PK/PD)
models and methods spanning and offering insights at basic, complex, and systems pharmacologic levels.
Overall, our goals are development of mechanistic pharmacologic and disease models that reveal and interrelate
the `rules of biology and pharmacology' at various levels of biological organization and allow improved
quantitation and prediction of in vivo hormone and drug effects. The cancer drug studies utilize cell cultures,
proteomics, and network analyses with an emphasis on seeking natural synergy of multiple agents and evolving
new methods for quantitating drug interactions. Our experimental paradigm for CS studies has been large
carefully controlled studies in groups of animals subjected to defined conditions or drug treatments (“giant rat”
studies). Blood and major organs will be harvested from male and female rats over timeframes reflecting either
endogenous biorhythms or the onset and recovery of changes produced by single drug doses or prolonged
disturbances of homeostasis produced by disease and chronic drug exposures. We examine involvement of
short rhythms (circadian) within longer biorhythms (estrous cycle, seasons), assess sex differences in disease
processes and steroid actions particularly in rheumatoid arthritis, and evolve and apply physiologically relevant
basic PK/PD to extensive systems pharmacologic approaches. Our methods and interdisciplinary collaborations
include extensive laboratory-based experiments, state-of-the-art bioanalysis methods, generation of “big data”
sets of –omics response data, various computational platforms, expert knowledge about diverse biological
processes, and offer the imagination and insights to recognize new principles that emerge and underlie the
complexities of how drugs, hormones, and natural compounds work and interact in the body. These efforts
encompass and enrich both basic PK/PD and systems modeling, but with emphasis on enhanced physiological
models that attend complex mechanisms of drug action. These holistic studies and mathematical modeling
innovations will provide improved multi-scale understanding of critical biological, hormone, and pharmacologic
functions and will continue to offer wide applications in quantitative pharmacology.

Public health relevance
Narrative The corticosteroids are highly important endogenous hormones as well as therapeutic agents with myriad effects on biological systems but having limitations in clinical use owing to diverse adverse metabolic responses. This program will extend the pursuit of carefully controlled, detailed studies of endogenous biorhythms, disease conditions, and pharmacologic responses to corticosteroids in blood and tissues comparing male and female rats. Studies of joint drug effects on pancreatic cancer cells will seek natural synergy, reveal altered signaling pathways, and provide new methods of assessing drug interactions. The development of advanced methodology and mathematical models that reveal and quantitate “the rules of biology and pharmacology” relevant to diverse hormones and drugs will complement these experimental studies.